The Patient-Reported Outcomes, Community-Engagement and Language (PRO-CEL) Core

ABSTRACT
The Patient-Reported Outcomes, Community Engagement, and Language (PRO-CEL) Core
enhances the objectives of the Center's research programs by supporting the array of MSK investigators who
wish to capture self-reported information from culturally varied patients, caregivers, clinical staff, and
community members. The faculty of the PRO-CEL Core are nationally recognized social, behavioral sciences,
and community engagement experts who provide technical assistance to all users throughout their various
stages of research, including grant and protocol development, research study assistant and support staff
training, and result dissemination. The PRO-CEL Core aims to 1) provide research consultation support and
training in the selection and/or design of specific patient-reported outcome (PRO) survey tools, as well as
measures to collect data from other key stakeholders (e.g., caregivers, physicians, nurses, community
members at high risk of cancer); 2) assist investigators in the design, implementation and analysis of all
aspects of qualitative research; 3) support MSK investigators who wish to incorporate PRO, qualitative and/
or community engagement research methods into peer-reviewed funding applications; and 4) provide
methodological support for clinical trial, behavioral, and population-based research that seeks to
engage community or understudied populations.